Sugar Probed SRS Volumetric imaging of Metabolic Activities

Project Summary
Visualizing metabolic activities in situ is critical to understanding many biological processes. It
is the metabolism which carries out the genetic blue print and maintain life. Sugar such as
glucose is an essential nutrient for human being and animals, not only provides energy, but
also is building blocks for synthesizing new biomass such as protein, lipid, RNA/DNA, and
glycogen. Our proposed study is to develop and optimize a new generation of deuterated
glucose ([D]-glucose) probed 3D volumetric multiplex stimulated Raman scattering (SRS)
imaging platform. In aim I, various types of [D]-glucose including [D1], [D2], [D5], [D7], and [D12]-
glucose will be studied and optimized for visualizing metabolic dynamics and heterogeneity in
animals. The carbon-deuterium (C-D) chemical bond in the newly synthesized molecules such
as C-D labeled proteins, lipids, DNA/RNA, carbohydrates will be imaged in the “cell silent
region” of Raman spectra. In addition, based on diverse spectral patterns of metabolites
derived from different isotopologues, metabolite synthesis in multiple time points will be
visualized in a single image. In Aim II, a new generation of enhanced tissue clearing recipe
will be screened and designed for large scale 3D volumetric imaging (20x deeper penetration)
of [D]-glucose probed metabolic activities and heterogeneity in animal models. In Aim III,
custom designed spectral unmixing algorithm and protocol will be established to maximize the
potential of detecting more than 20 newly synthesized C-D labeled molecules and minimize
the background signal. Our computational resources and algorithms will optimize numerous
variables in complicated hyperspectral imaging datasets for studying organ specific metabolic
dynamics and heterogeneity. Using the resources and algorithms, we will optimize a platform
to unmix multiple old and newly synthesized molecules and quantitatively dissect the in situ
detritions. Completion of the proposed study will potentially reveal mechanistic fundamentals
of multiple molecular pathways related to glucose metabolism in different organs.

Public health relevance
Project Narrative The mechanistic basis of many biological processes, such as development, aging, homeostasis, and response to stimuli can be revealed from understanding of metabolism, and there is an urgent need for the imaging platform to visualize 3D volumetric metabolic dynamics and heterogeneity in live cells and tissues. Our proposed study is to develop and optimize a state-of-the-art 3D imaging platform that combining a new generation of deuterated glucose- probed stimulated Raman scattering microscopy with upgraded tissue clearing recipes and custom designed spectral linear unmixing algorithm, for visualizing large volumetric distribution of more than 20 newly synthesized molecules in animal models for studying metabolic pathways.